An Interoperable, Reusable and Scalable Shared Decision Aid Navigator System: Supporting the 5 Rights of Patient Shared Decision-Making

Project Summary/Abstract
For clinical decision support to be effective it must provide the right information, to the right persons, at the
right times, in the right formats, and via the right channels (aka ‘“The 5 Rights of CDS”). The “5 Rights of CDS”
framework also applies to shared decision-making support. Shared decision-making is a patient-centered form
of clinical decision-making. Patient decision aids (PDAs) are increasingly recognized as valuable tools to
support shared decision making, and several are mandated by CMS for coverage determinations. To facilitate
successful PDA implementation a PDA containing the right information must be provided to the right patient at
the right time, in the right format, and be delivered in the right channel. Despite the proven clinical benefits of
PDAs, informatics systems to reduce the barriers health systems, physicians, and patients face in using PDAs
are lacking. Known limitations of PDA use include having to locate the right PDA, knowing the quality of the
PDA, having to leave the electronic health record (EHR) environment to find and use the PDA, having to
manually enter data into the PDA, and documenting the process of shared decision-making that was
undertaken. The objective of this proposal is to create an informatics system that addresses know PDA
implementation barriers, supports the “5 Rights” framework, and is built to be reusable, interoperable, and
scalable. The proposed Shared Decision Aid Navigator System (SDANS) will address PDA implementation
limitations by (1) creating a repository of the PDAs metadata needed to support “5 Rights” implementation, (2)
creating a SMARonFHIR (SoF) EHR-embedded PDA navigator that relies on PDA metadata, patient data, and
organizational data to implement the “5 Rights” and to support documentation (3) using the Fast Healthcare
Interoperability Resources (FHIR) standard to retrieve patient data that can be used to support the “5 Rights” of
implementation and to provide data to data-enabled PDA tools, (4) using CQL and creating a Clinical Quality
Rules (CQL) rules repository to maintain PDA implementation rules, and (5) creating an administrative
application for health systems and practices to modify and maintain their PDA repository and CQL
implementation rules. In Aim 1 we will employ co-design principles and qualitative methods with patients,
clinicians, and health information technology (HIT) experts to design and build the SDANS to ensure it meets
the needs of those who will use the system. We will also convert three current high-quality, evidence-based
CMS-mandated PDAs into SMARTonFHIR applications to allow us to test the full functionality of the SDANS.
In Aim 2, four medical centers will deploy the SDANS and the three SOF-converted PDAs into a proof-of-
concept environment and we will evaluate the feasibility, functionality and satisfaction with the system. In the
long-term, the SDANS will lead to improved implementation of PDAs and meet AHRQ’s mission to improve the
use of CDS, including PDAs, and to improved patient-centered outcomes.

Public health relevance
Project Narrative When patients and providers use patient decision aids (PDAs) patients report improved knowledge, satisfaction, patient-provider communication, increased involvement in decision making, and reduced decisional conflict and regret. Despite these meaningful patient-centered outcomes, PDAs continue to be underutilized. We propose to use user-centered design methods to build and test a shared decision aid support system that addresses the patient, clinician, and system barriers to PDA use, supports alignment with the “5 rights of clinical decision support”, and supports reusability, interoperability, and scalability.